Genetics of adipose cell-type expression and cardiometabolic traits

Abstract
A global obesity epidemic is driving the concomitant rapid increase in the prevalence of cardiometabolic
disorders (CMDs), including hypertriglyceridemia, type 2 diabetes (T2D), hypertension, and non-alcoholic fatty
liver disease (NAFLD). Population- and sex-specific differences in CMD predisposition exist; however, the
biological mechanisms underlying these differences are not well understood. Previous large-scale genome-wide
association studies (GWAS) have reliably identified CMD-associated variants in multiple populations; however,
functional understanding of the biological mechanisms of the GWAS variants remains challenging. One major
obstacle is the limited knowledge of the relevant cell types in which GWAS variants affect gene expression. Bulk
tissue gene expression data exist for CMD-relevant tissues, such as subcutaneous adipose, but these data
exhibit considerable heterogeneity, including both cell type and cell state within each cell type. Subcutaneous
adipose is an important human endocrine tissue for CMDs, and it is possible to collect high-quality adipose tissue
samples from healthy individuals. However, the contributions of many adipose genes to CMDs and CMD traits
are still poorly understood. The current lack of cell-type expression reference data sets limits fine-scale regional
transcriptional assessment of GWAS variant effects. In addition, local expression quantitative trait locus (cis-
eQTL) analyses are confounded by cell-type-specific expression differences, which hamper replication efforts
across independent bulk RNA-sequenced (RNA-seq) cohorts. To address these knowledge gaps and identify
genetic effects on adipose cell-type gene expression, we will perform single nucleus RNA-sequencing (snRNA-
seq) in frozen subcutaneous adipose tissue biopsy samples from 300 well-characterized individuals, generate
fine-scale estimates of cell-type proportions, identify study-wide and personalized cell-type-specific differences
corresponding to cardiometabolic trait levels, and experimentally test GWAS variants for allelic effects on cell-
type-specific expression. We hypothesize that by elucidating adipose tissue cell-type expression from 300
existing frozen adipose biopsies, we can leverage available GWAS and adipose bulk RNA-seq data (n=3,230;
45% female) from diverse populations to identify the relevant cell types for hundreds of CMD genes. In our
preliminary studies, we have successfully performed snRNA-seq in frozen human subcutaneous adipose tissue
biopsies and performed multi-omic studies integrating GWAS results with bulk adipose RNA-seq data, identifying
hundreds of colocalized loci for CMD traits. Our approach will leverage the existing wealth of information
available in GWAS and bulk adipose RNA-seq cohorts to elucidate the largely unknown cell types of biological
mechanisms in the adipose tissue that drive CMDs. Success of the proposed study will substantially improve
understanding of cell-type-specific transcriptional mechanisms of CMD diseases and traits in a key human
metabolic tissue.

Public health relevance
PROJECT NARRATIVE The prevalence of obesogenic cardiometabolic disorders (CMDs) is increasing alarmingly worldwide. Previous large-scale genome-wide association studies (GWAS) have reliably identified CMD-associated variants; however, their cell-type-specific mechanisms have remained largely elusive. To address this scientific knowledge gap and further our understanding of gene expression at a single cell level, we will perform single nucleus RNA-sequencing in 300 subcutaneous adipose tissue samples to generate fine-scale estimates of cell-type proportions; identify study-wide and personalized cell-type-specific differences corresponding to cardiometabolic trait levels; and characterize GWAS variants that underlie CMDs by altering cell-type-specific expression.